The Cellular and Systems Biology of Sleep and Circadian Rhythms Training Program

Project Summary
This is a resubmission of a new competitive proposal for an NHLBI T32 training grant.
Sleep/wake and circadian rhythms involve state changes of multisystem biological function that
may not in themselves be vital to life but the systems under this modulatory control are vital to
life. Further, optimal function of these systems, required for healthy living, is severely
compromised in the absence of these intricately organized state changes.
The regular and/or rhythmic occurrence of state changes is evolutionarily preserved and adverse
outcomes in a variety of organ systems, including CNS, cardiovascular, respiratory, immune, and
metabolic systems are associated with their disruption. However, the mechanisms, the
mechanisms’ integration and both qualitative and quantitative impact of the state-change
related modulation and overall health of the organism (including humans) is not well understood.
An overall goal of this T32 proposal is to prepare a group of pre-doctoral and post-doctoral
researchers to engage in the challenging endeavor of effective investigation to help remedy this
vitally important gap in our biological understanding. Not only will the trainees receive in depth
exposure and experience in effective application of multiple and integrated state of the art
technologies and experimental approaches from world leaders, but additionally, strong
integrative and collaborative interaction and facilitation of this interaction will be generated from
our proposed structure within the newly developed Peter O’Donnell Brain Institute. This will
enhance the trainee’s ability to engage in independent development of successful research
programs that truly span the usual gulf from bench to bedside in a manner that integrates
multiple biological systems across behavioral states as demanded by effective sleep/wake and
circadian research. Finally, trainees will receive mentored experience in grant writing and in the
communication and publication of integrative form of research and career counseling to enabling
successful pursuit of a sleep and circadian research oriented career.

Public health relevance
Project Narrative Sleep and circadian rhythms are necessary for a healthy long-lasting life and their disruption is strongly associated with CNS, cardiovascular, respiratory, immune, and metabolic pathology. However, we have little understanding of the function of these state changes in maintaining human health. We are in critical need of scientists and physician-scientists to fill this gap, so vital to improving our healthy well-being and aging that is training grant will provide.